PET Imaging for neuroinflammation in Alzheimer's disease

Project Summary
There are no efficacious therapies available to halt or reverse AD progression, which is attributed to, in part,
the lack of translational cross-species biomarkers suitable in both preclinical disease models and humans to
facilitate drug discovery and development process. Therefore, development of translatable imaging biomarkers
for non-invasive assessment of disease progression and therapeutic efficacy hold promises to fill the gap of this
urgent and unmet clinical need. Growing evidence indicates altered microglia and neuroimmune function
disruption occurs early in the AD pathophysiology. We have also seen that early intervention against
neuroinflammation could substantially impact the incidence and progression of AD. Herein we propose the use
of a novel imaging strategy for monitoring innate immune function, neuroinflammation, and microglia-modulating
treatment response in AD therapy. Our strategy involves the use of a specific positron emission tomography
(PET) tracer [18F]JNJ-739 targeting purinergic P2X7 receptor (P2X7R). Increased P2X7R expression has been
found in microglial cells surrounding amyloid plaques both in AD patients and different AD mouse models, which
parallels with AD progression. [18F]JNJ-739 is the only validated P2X7R PET tracer that showed high
permeability and specific binding in the brain of nonhuman primates and has recently translated to human use.
The ligand possesses excellent binding affinity (IC50 1.0 nM) and high selectivity (>100 fold) towards any other
major CNS targets. The PI and his team have evaluated brain kinetic and specific binding of [18F]JNJ-739 in
neuroinflammation mouse models. Our preliminary studies have shown that [18F]JNJ-739-PET can detect and
monitor neuroinflammation in LPS-induced neuroinflammation mouse models, which was well-correlated with
our immunohistological findings.
To date, there is no direct non-invasive in vivo measurement of the distribution and expression of P2X7R in
various AD stages, representing a substantial knowledge gap and opportunity to study microglia activation and
innate immune function by [18F]JNJ-739-PET. Our hypothesis entails that increased P2X7R brain binding,
determined by [18F]JNJ-739-PET, is correlated with AD symptom severity, increased neuroinflammation,
activated microglia and severe innate immune disruption, as well as high Aβ/tau production. Therefore, as our
specific objectives, utilizing non-invasive [18F]JNJ-739-PET, we propose to directly monitor P2X7R changes in
the brain as an index of neuroinflammation and altered microglia in AD, and determine target engagement.
Following this, our long-term goal is to assess the utility of [18F]JNJ-739-PET as a translational biomarker to
provide new information of AD pathophysiology and to evaluate treatment response in clinical trials of novel AD
drugs.

Public health relevance
Project Narrative As the burden of neurodegenerative diseases in the United States and worldwide is high, there is a critical need to develop novel PET ligands to image and monitor neuroinflammation and altered microglia function in the brain. This work will develop key imaging tools designed to advance the scientific understanding of pathophysiology of Alzheimer’s disease.